PHASE II STUDY OF L PAM PLUS BSO IN PATIENTS W/ METASTATIC MELANOMA

This protocol will evaluate the antitumor activity of melphalan (L-PAM) and L-buthionine sulfoximine (BSO) in patients with metastatic melanoma. The effect of BSO pretreatment on glutathione metabolism in peripheral blood lymphocytes and tumor tissue, as well as BSO pharmacodynamics, will be studied.